Programming Support for the NCI SEER program

This contract provides programming support to enhance data from the National Cancer Institute's Surveillance, Epidemiology, and End Results (SEER) program with data from the Center for Medicare and Medicaid. The SEER program is managed by the Surveilance Research Program loacted within the Division of Cancer Control and Population Sciences at the National Cancer Institute.